Physics of Living Matter: From Molecule to Embryo.

ABSTRACT
Shape is critical for proper organ function. For example, neural tube morphogenesis lays the foundations of
brain and spine. Neural tube defects that fail to close the tube have devastating consequences for the body.
Despite success with folic acid treatment, we are still missing effective treatment strategies. From genetic
model systems, we have learned much about the principles of how morphogens setup body axes, and trigger a
cascade of regulatory factors that precisely pattern the organism, endowing each cell with a unique fate.
However, morphogenesis, the question of how genes instruct form, also involves aspects of mechanics. Tissue
folding requires the coordinated action of forces that dramatically change the form of the organ. From single
cell studies in vitro, we have learned how cells utilize fundamentally dynamic processes that involve their
cytoskeleton to generate forces. However, how forces are coordinated across tissues to reliably generate form
remains elusive. Progress requires extending molecular analysis to investigation of cellular dynamics at the
organ level, to study the interplay of forces and cell behaviors.
Organ shape is instructed by patterns of forces generated from dynamic processes observed in cell behaviors.
While we are beginning to monitor the dynamics of cell behaviors, measuring these force patterns in animal
model systems remains very challenging. Moreover, animal development differs in key aspects from humans.
This is particularly true for neural development, and its derived structure the brain. To overcome these hurdles,
we have developed a new stem cell model for neural tube closure in a human genetic context. Our approach is
inspired by embryogenesis, and first organizes cells into a closed sheet surrounding a lumen. In this way we
guide stem cells in terms of fate and form, but leave enough room for a dynamic, and self-organized
morphogenetic program. The results are multiple complex and interacting human tissues, which exhibit striking
similarity to the in vivo analogue in terms of genetic pattern, shape, and reproducibility.
This proposal seeks to enter new territory in the study of mechanical aspects of neural tube closure in a human
genetic context. To this end, we exploit the unique capabilities of our stem cell model system to undergo
complex morphogenetic processes in the precisely controlled and for quantitative measurements highly
suitable environment of a petri dish. Specifically, this environment allows us to directly measure absolute levels
of forces in a faithful stem cell model of human neural tube closure. In addition, this setup allows us to
investigate how cells handle geometric constraints at the tissue level – a process that has been linked with one
of the most devastating forms of neural tube closure defects. Our stem cell-based approach will open up new
paths towards deciphering how human genetics works in health and disease.

Public health relevance
NARRATIVE Despite successful folic acid treatment, one in 500 live births in the US suffer from early failures in closing the neural tube, a progenitor of brain and spine - depending on severity often resulting in stillbirths or extremely short live spans. In this study we leverage a recently developed stem cell-based model system of neural tube closure to study the mechanical aspects of this process, required to identify cellular, and genetic mechanisms underlying proper tube closure.